The Role of Histone Deacetylase 6 in Oral Bacteria-Mediated Periodontal Inflammation

Project Summary/Abstract:
Periodontitis is a chronic inflammatory disease induced by bacterial infection within the periodontium and affects
almost 50% of adults in the United States. Unresolved inflammation in this area results in the breakdown of the
periodontal ligament and alveolar bone which can lead to subsequent tooth loss. While the presence of bacteria
initiates periodontitis, it is ultimately not the sole factor that drives disease progression. The inflammatory
response is critical for the eradication of bacterial invaders, however the dysregulation of these mechanisms and
overproduction of pro-inflammatory cytokines such as TNF-α, IL-6, IL-12 p40, and Macrophage Inflammatory
Protein 2 (MIP-2) have been implicated in the progression of tissue damage in the periodontium and in other
chronic inflammatory diseases. Histone deacetylase 6 (HDAC6) is a member of the class II HDACs located in
the cytoplasm that can deacetylate specific non-histone proteins and facilitate their translocation to the nucleus.
This deacetylation has been reported to alter production of inflammatory mediators in response to the stimulation
of microbe-associated molecular patterns (MAMPs). Our preliminary results have shown that stimulation of
innate immune cells with Porphyromonas gingivalis, a major pathogenic bacterium associated with chronic
periodontitis, resulted in phosphorylation of class II HDACs and subsequent deacetylation of FoxO1, which will
enhance its binding to the FoxO-binding element and thus promote associated pro-inflammatory mediator
production. Likewise, selective inhibition of HDAC6 resulted in a decrease in pro-inflammatory cytokine
production through increasing cytosolic translocation of FoxO1 and subsequently decreased its binding to the
promoter of C/EBP-β after P. gingivalis infection. Therefore, using P. gingivalis as a model organism, we
hypothesize that oral bacterial pathogens activate HDAC6 and enhance the inflammatory response
through facilitating the deacetylation and nuclear translocation of FoxO1, subsequently enhancing the
expression of downstream pro-inflammatory mediators. We will test this hypothesis using two aims.
Experiments proposed for Aim 1 will investigate the role of HDAC6 in the inflammatory response by observing
the production of inflammatory cytokines and the migration of neutrophils and will also delineate the downstream
signaling of HDAC6 in different immune cells in response to P. gingivalis challenge. In Aim 2, we will examine
the in vivo relevancy of HDAC6 signaling in gingival tissue inflammatory responses to oral bacterial infection and
alveolar bone loss. These aims will establish the regulatory function of HDAC6-mediated differential inflammatory
mediator secretion in the control of immune responses. The long-term goal of this proposed work will be to
identify novel interventional therapeutic targets and regulatory mechanisms of periodontal inflammation that may
be broadly applicable to other inflammatory diseases.

Public health relevance
Project Narrative Inflammation is a double-edged sword, with the ability to rid the body of invading microorganisms and to cause collateral tissue damage when these mechanisms are out of balance. Oral bacteria such as Porphyromonas gingivalis, one of the main causative agents in the progression of periodontal disease, employ different strategies of subverting or enhancing the immune response to facilitate their own survival. Elucidating these methods of survival will ultimately lead to novel therapeutic targets to prevent bacteria-induced inflammation and to treat periodontitis.